Single molecule studies of titin elasticity

DESCRIPTION (provided by applicant): The giant protein titin is responsible for the elasticity of heart muscle, playing a key role in the circulation of blood in humans. The filling with blood o the left ventricle of the human heart during diastole, and its subsequent ability to eject it throuh the aorta, is dependent on the elasticity of titin. The elasticity of heart muscle is regulated in ivo by redox signaling and modified by genetic mutations. Indeed, genetic mutations of the titin gene were found to be a primary cause of dilated cardiomyopathies, one of the most common forms of heart disease. We are far from understanding how redox signaling or mutations can alter the elasticity of this giant 35,000-amino-acid long titin protein in the human heart, which remains a formidable challenge. Titin operates in vivo under a mechanical load, making it difficult to study it with classical protein biochemistry techniques, greatly limiting our understanding of how this protein functions. Here we aim to use state-of-the-art single molecule force spectroscopy techniques to identify the molecular basis of regulation of titin elasticity by redox signaling. We will examine the hypothesis that nitric oxide signaling increases titin elasticity by modifying buried cysteine residues of the elastic I-band that become exposed when titin is mechanically stretched. We will also examine the hypothesis that oxidative stress triggers the opposite effect, by stiffening titin through the formation of buried disulfide bonds that limitthe extensibility of the protein. We will utilize proteomics techniques to identify residues targeted b redox modifications in native titin molecules purified from human cardiac tissue. Thus, our proposal aims to identify the key residues involved in the physiological regulation of titin elasticity in vivo, and their mode of action. We will apply our findings to develop the first full computational model of human cardiac titin elasticity. This model will be based on our current knowledge of the physics and chemistry of titin. Our aim is to identify all the key residues controlling the mechanical properties of titin, and then implement a gene-to-phenotype mathematical model based on Monte Carlo and Brownian Dynamics, to predict the elastic response of the protein to different types of physiological or pathological stimuli, such those mimicking exercise or infarction. We will validate this model with the known effects of redox signaling, and with a growing genomic database of titin mutations associated with heart muscle disease. Such a synthesis of the physics of titin elasticity with its chemical regulation by cellulr signaling has never been attempted before, and will provide the first quantitative tool to uncover the etiology of numerous muscle tissue diseases. A highly developed version of this model may be used to evaluate the severity of heart muscle phenotypes in humans that are discovered to have mutations in the titin gene.

Public health relevance
PUBLIC HEALTH RELEVANCE: The giant protein titin is responsible for the elasticity of heart muscle. Genetic mutations of the titin gene cause dilated cardiomyopathies, one the most common types of heart muscle diseases. We will use advanced single molecule techniques to uncover the molecular targets of physiological regulation of titin elasticity. Based on our finding, we will develop the first full-scale model of titin, which can be used to predict the severity of diseases resulting from abnormal cellular regulation and from genetic mutations in the titin gene.